MEDUSA(GM): an analysis platform for resolving mechanisms of action for anti-cancer drugs

PROJECT SUMMARY/ABSTRACT
Understanding mechanisms of drug action is important for identifying settings in which a drug will be effective,
and for interpreting – even predicting – potential mechanisms of drug resistance. For anti-cancer drugs, a key
aspect of their mechanism of action is the mechanism by which these drugs promote cell death. The first
identified death pathway was apoptosis, a form of death that is now reasonably understood. In addition, the
community has now identified at least ten distinct forms of regulated necrosis. Our recent studies highlight that
these non-apoptotic forms of cell death contribute to the efficacy of many anti-cancer therapies, with each form
of non-apoptotic death activated by at least one clinically used compound. A current limitation in the use of
drugs that activate non-apoptotic forms of death is that we lack a detailed understanding of how most of these
pathways function. To address this issue, we recently developed MEDUSA (Method for Evaluating Death
Using a Simulation-assisted Approach). MEDUSA is an analytical method used to evaluate genome-wide
CRISPR screens of drug efficacy (which are sometimes referred to as “chemo-genetic profiles”). Our recent
publications demonstrate that MEDUSA is uniquely effective at revealing a drug’s mechanism of action and
mechanisms of drug-induced lethality, including the signaling and regulatory pathways that facilitate activation
of cell death. Furthermore, while many methods exist for evaluating apoptotic death – due to the stability of the
apoptotic corpse and the existence of measurable biomarkers that are specific to apoptotic cells – MEDUSA is
likely the only method that will be effective at identifying the genetic dependencies and mechanisms of
resistance for drugs that activate non-apoptotic forms of cell death. Although MEDUSA is effective, it requires:
1) a detailed understanding of drug function to parameterize a drug-specific simulation, 2) specialized
experimental requirements, such as time-resolved data, which are not common in most experiments, and 3)
programming proficiency to run the MEDUSA simulations. The central goal of this proposal is to extend the
MEDUSA method, to enable easier use and broad utility, particularly in the evaluation of publicly available
data. We call our new version MEDUSA: Generalized Method (MEDUSA(GM)). This new method: 1) can be
used without any drug-specific information, 2) does not require any specialized data, and 3) will be available on
a web portal and can be used without any programming. In this proposal, we will add new functions to our
MEDUSA(GM) method, stress test the MEDUSA(GM) method with therapeutically relevant drug scenarios that
have not been previously evaluated, and develop the MEDUSA(GM) web portal, which will enable open access
use of MEDUSA(GM).

Public health relevance
PUBLIC HEALTH RELEVANCE Recent studies have uncovered the existence of at least 15 mechanistically distinct forms of regulated cell death, and commonly used anti-cancer drugs have the ability to activate many, if not all, of these pathways. Understanding which forms of cell death are activated by a drug is critical for predicting mechanisms of drug resistance and for improving drug efficacy; however, this information is not currently known due to the lack of tools needed to simultaneously evaluate all types of cell death. This proposal aims to develop new tools to enable a comprehensive evaluation of which forms of cell death are activated by a drug, and how these features vary across patients, disease types, and treatment contexts.